South Carolina Center Health Equity Consortium (SC CHEC): Summer Undergraduate Research Training Program Ã¢ÂÂ Administrative Supplement

The Medical University of South Carolina (MUSC), the University of South Carolina (USC), and three historically black colleges/universities – Claflin University (CU), South Carolina State University (SCSU), and Voorhees College (VC) – have joined forces under the larger aegis of the South Carolina Cancer Health Equity Consortium (SC CHEC) to develop this application for an R25E NIH/NCI Cancer Education Grants Program. Together, these institutions have created an innovative, inter-institutional, 14-week summer course. This is combined with a hands-on laboratory research training platform and career mentoring by some of the nation's leading cancer researchers to attract and catalyze a new generation of diverse biomedical scientists. Within this new five-year initiative, 80 undergraduate juniors and seniors (designated as SC CHEC Student Fellows) from USC, CU, SCSU, and VC will engage with investigators at the MUSC Hollings Cancer Center, a National Cancer Institute (NCI) designated cancer center, to expose them to the latest advances in biomedical research spanning basic, clinical, and population sciences with an emphasis on cancer disparity dynamics in South Carolina (SC). The curriculum and training of this new initiative are focused on four of the most disparate cancers in terms of incidence, morbidity, and mortality in SC ? breast, prostate, head/neck, and cervical cancer. Health outcomes for patients diagnosed with these four cancers are strongly influenced by race, ethnicity, urban/rural residence, socioeconomic position, and potentially biology. This R25E program's primary strategy will employ in-person classroom and laboratory instruction within the context of contemporary scientific approaches to cancer research at MUSC. These will be complemented by selected clinical and biotechnology-focused rotations, community engagement, and Graduate Record Examination preparation. The SC CHEC leadership strongly believes that promoting interest, career development, and commitment from the Millennial Generation (those born in the 1990s) to cancer biomedical and biobehavioral research is a critical step to attaining health equity and improved health outcomes in SC and beyond. Unfortunately, due to the COVID-19 pandemic, during the summer of 2020, the SC CHEC program was unable to provide the cancer research training to undergraduate students in SC that is such a vital resource in kick-starting their academic research careers. The SC CHEC is a high-impact program. Since its inception in 2016, 100% of the 61 SC CHEC Student Fellows are either still enrolled in undergraduate college/university or are enrolled in graduate/professional school. The 61 SC CHEC Student Fellows have given 77 scientific presentations and co-authored 4 peer-reviewed publications (with several additional manuscripts in progress. The funding provided through this Administrative Supplement will allow us to continue this valuable and important work.

Public health relevance
The R25E Program combines an innovative, inter-institutional, 10-week, summer course with hands-on laboratory research training and career mentoring by some of the nation's leading cancer researchers to attract and catalyze a new generation of diverse biomedical scientists. This five-year initiative focuses on four of the most disparate cancers nationally and in SC in terms of incidence, morbidity, and mortality (breast, prostate, head/neck, and cervical cancer) and within this initiative, more than 80 undergraduate juniors and seniors from the University of South Carolina, and three historically black colleges/universities – Claflin University, South Carolina State University, and Voorhees College – will receive cancer research training at the Medical University of South Carolina; to date, 100% of the 61 SC CHEC Student Fellows are either still enrolled in undergraduate college/university or are enrolled in graduate/professional school. The 61 SC CHEC Student Fellows have given 77 scientific presentations and co-authored 4 peer-reviewed publications (with several additional manuscripts in progress); while the COVID-19 pandemic, during the summer of 2020, the SC CHEC program was unable to provide the cancer research training to undergraduate students in SC that is such a vital resource in kick-starting their academic research careers, the funding provided through this Administrative Supplement will allow us to continue this valuable and important work.